Fluorescence lifetime-based intraoperative imaging system for sarcoma surgeries

Abstract: Surgical resection is the primary method of treatment for sarcomas. The standard clinical approach
relies on pre-operative imaging, intraoperative palpation and visual inspection, and additional intraoperative
frozen sections of biopsies in areas of concern. These methods are subjective, unreliable, and do not provide
real-time feedback to the operating surgeon. This leads to microscopically and macroscopically positive margin
resections which correlate with the development of local recurrence and of metastases, increasing patient
morbidity and mortality. On the other hand, excessive removal of tissue could lead to unnecessary morbidity
and loss of normal function. There is a vital need for intra-operative techniques that can provide accurate and
immediate feedback regarding the presence of residual cancer in the surgical bed, ensuring complete tumor
removal while minimizing loss of healthy tissue, subsequently reducing recurrence rates, and improving the
quality of life of patients. Fluorescence imaging using exogenous contrast agents is being evaluated for
enhancing tumor visualization during surgeries. However, a major drawback is the presence of non-specific
fluorescence in normal tissue, which reduces accuracy. Traditional fluorescence imaging detects total light
intensity, which is a relative parameter that strongly depends on probe uptake in tissue, tumor size, tissue
attenuation and system-specific measurement parameters, making comparisons across different
measurements and imaging systems difficult. Fluorescence lifetime (FLT) imaging is an alternative approach
where the decay rate of photons emitted by the fluorophore is measured. FLT is not affected by changes in
brightness of the light source, dye uptake, and tissue attenuation. FLT imaging of endogenous chromophores
in the visible spectrum has been evaluated for tumor imaging. However, the clinical utility of endogenous FLT
imaging has been limited due to poor contrast between tumor and normal tissue. We have shown that FLT
imaging in combination with exogeneous near infrared agents, including the FDA approved Indocyanine green
(ICG), significantly improves the detection sensitivity and accuracy of tumor vs. normal classification in multiple
cancer types, including different histologic subtypes of sarcomas. FLT can differentiate between cancer cells
and non-specific fluorescence background even at a microscopic level. Building on these exciting results, we
propose to develop and validate a wide-field FLT imaging system for open surgery of sarcomas and other
cancers. We will develop a portable wide-field time domain fluorescence imaging system and incorporate
algorithms for real-time FLT imaging of the surgical bed. We will then perform a preclinical validation, followed
by a clinical study to optimize the system for intraoperative imaging of sarcomas, and validate the accuracy of
FLT imaging by comparing with gold standard pathology. This proposal brings together a team with extensive
experience in fluorescence imaging, sarcoma surgeries and pathology to develop the first intraoperative
imaging system capable of wide-field NIR FLT imaging for cancer surgery.

Public health relevance
There is an urgent need for imaging methods that can allow surgeons to distinguish cancer from heathy tissue during surgery of bone and soft tissue sarcomas, to ensure that the tumor is fully removed and to preserve healthy tissue and function. We will test an optical imaging system that captures differences between the decay time of light emitted from tumors and normal tissue in patients who are injected with fluorescent dyes and undergoing surgery of bone and soft tissue sarcomas.